Placental barrier culture to delineate the mechanism of hepatitis E virus infection at the maternal and fetal interface

Project Summary: Hepatitis E virus (HEV) infects >20 million people worldwide annually leading to 3.3 million clinical
cases of hepatitis and >44,000 deaths due to hepatobiliary diseases. As a non-enveloped virus, HEV is surprisingly present
as quasi-enveloped exosome-like virions in circulating blood that resist neutralization. Genotype 1 HEV (HEV-1) infection
is associated with fulminant hepatitis with high mortality (>25%) in pregnant women. HEV-1 replicates in placental tissues,
and HEV-1 vertical transmission is associated with a high neonatal mortality. Due to the lack of an efficient cell culture or
animal model for HEV-1, the mechanism of HEV-1-associated severe diseases during pregnancy is unknown. Significantly
higher levels of TNF-α were found in HEV-infected pregnant women with fulminant hepatitis, and HEV-infected pigs with
detectable HEV RNA in CNS tissues had significantly higher levels of proinflammatory cytokines (TNF-α and IL-18) than
in pigs without detectable HEV RNA in CNS tissues. The long-term goal is to delineate the mechanisms contributing to
HEV-associated high mortality during pregnancy. Unfortunately, we currently do not have a suitable system, in vitro or in
vivo, to study HEV-1 infection at the maternal-fetal interface. In aim 1, we will establish an in vitro placental barrier in
Transwell insert to study HEV-1 infection in the maternal-fetal interface. We hypothesize that HEV-1 in circulating blood
during peak viremia crosses the placental barrier leading to fetal infection. We will develop a placental barrier culture
mimicking the critical maternal blood- and fetal blood-facing layers that constitute the human placental barrier in vivo, by
co-culturing BeWo placental trophoblastic cells and human umbilical vein endothelial cells on basolateral and apical sides
of an extracellular matrix-coated Transwell insert. The integrity of the barrier will be confirmed by measuring TEER and
barrier permeability to small molecules. We will determine whether HEV-1 can cross the barrier by infecting barrier cultures
in the maternal chamber with HEV-1 and HEV-3, respectively, and measuring the amount of HEV in the fetal chamber of
the barrier. In aim 2, we will determine the mechanisms of HEV-1 infection in the maternal-fetal interface leading to fetal
infection. We hypothesize that quasi-enveloped exosome-like HEVs in circulating maternal blood during peak viremia
more easily cross the placental barrier when the barrier is inflamed by pro-inflammatory cytokines such as TNF-α and IL-
18 that are consistently produced during HEV infection, and that HEV-1 infection in the barrier produces type III IFNs to
limit viral infection. We will inflame the barrier cultures with TNF-α and IL-18, separately or in combination, and then
infect them with non-enveloped HEV-1, HEV-3, quasi-enveloped HEV-1, HEV-3, respectively, to determine the amounts
of HEV that have crossed the barrier. We will also determine the expression levels of IFN-α, IFN-β and IFN-λs in infected
cells, and determine if the antiviral resistance environment induced at the barrier can be transferred to HEV-susceptible liver
cells. We anticipate to establish a placental barrier mimicking the critical maternal blood- and fetal blood-facing layers in
vivo, and show that quasi-enveloped HEV-1 will more easily cross the barrier especially when the barrier is inflamed with
proinflammatory cytokines TNF-α and IL-18. We also expect that HEV-1 induces IFN-λ1/λ2/λ3 in the barrier to limit virus
replication, and that the antiviral resistance environment induced at the barrier is transferable to HEV-susceptible liver cells.

Public health relevance
Project Narrative Hepatitis E virus (HEV) infection causes fulminant hepatitis with high maternal and fetal mortality in pregnant women but the underlying mechanism is unknown. We will establish an in vitro placental barrier culture model that mimics the critical maternal blood- and fetal blood-facing layers in vivo to delineate the mechanisms of HEV-associated severe diseases during pregnancy. The information gained from this small R03 project will have important implications for devising effective strategies for the prevention and treatment of HEV-associated high mortality in pregnant women.